Integrating cervical cancer screening within the outpatient emergency departments in Kenya

Integrating cervical cancer screening within the outpatient emergency departments in Kenya
This application is in response to Notice of Special Interest (NOSI): Administrative Supplements for NCI Global
Oncology Mentored Research Notice Number: NOT-CA-24-028.
Our U54 grant “Enhanced BReast and cErvical cAncer screening in Kenya THROUGH implementation
science research and training (BREAKTHROUGH) Center led by Drs. Michael Chung (Emory), Mohammed Ali
(Emory) and John Kinuthia (KNH) aim to inform the effective and sustainable integration of early detection and
successful treatment of precancerous cervical lesions in primary care for women in Kenya. We propose in this
supplement application to explore acceptability, barriers, facilitators and strategies to integrate cervical cancer
screening into outpatient emergency departments. The proposed study will provide an opportunity for research
training and mentorship of Dr. Rita Arogo, a Gynaecologist at Kenyatta National Hospital and Honorary lecturer
at the University of Nairobi, provide preliminary data for her K43 application and will complement the currently
ongoing U54 award by accessing women missed by current screening approaches.
Kenya's guidelines recommend cervical cancer screening for all women, but coverage remains low at
16%. Cervical cancer screening is primarily offered in maternal-and-child health, family planning, and HIV
comprehensive care clinics, leaving out women not seeking care in these clinics. Outpatient emergency
departments offer an opportunity to reach these underserved women. Understanding barriers and facilitators to
integrating screening in outpatient emergency departments can inform strategies to optimize screening.
The specific objectives of this mentored research are to: To assess the acceptability of cervical cancer
screening among women presenting to 3 outpatient emergency departments within Nairobi County, explore
barriers and facilitators of integrating cervical cancer screening services in the outpatient emergency
departments within Nairobi County and to identify feasible, and effective strategies to promote integration of
cervical cancer screening in the outpatient departments and develop roadmaps for implementation.
We will employ an explanatory sequential design, conducting 369 quantitative surveys followed by 36
qualitative in-depth interviews at three Nairobi County health facilities' outpatient emergency departments.
Using the Consolidated Framework for Implementation Research, we will conduct 15 in-depth interviews with
healthcare workers to grasp their perceived barriers and facilitators to the integration. Key stakeholders will
then convene in a 2-day workshop to prioritize identified barriers and propose implementation strategies. This
approach aims to promote cervical cancer screening uptake, capturing missed women and bolstering national
screening initiatives.

Public health relevance
PROJECT NARRATIVE A majority of the women in Kenya, who are not pregnant, breastfeeding, or seeking family planning services are often missed by the current cervical cancer screening initiatives integrated in these special clinics providing such services. Outpatient emergency departments present an opportunity to reach many women at the initial point of contact with the health care system. This project seeks to understand the acceptability, barriers, and facilitators to integrating cervical cancer screening into the existing outpatient emergency departments and will provide important insights into its feasibility allowing the formulation and adaptation of strategies to promote its implementation in many outpatient clinics in Kenya and other LMICs with low cervical cancer screening.